Data Core

Modified Project Summary/Abstract Section

The purpose of the Data Core is to centralize data activities across the three Projects of the proposed Autism Center of Excellence, “Public Health and Autism Science advancing Effectual Strategies across the life course (PHASES)” that utilize dynamic health data. The design of the proposed Data Core facilitates the confluence of expertise to acquire, store, manage, and analyze dynamic health data across sources: electronic health records (EHR), national administrative claims, mortality data, and small area contextual data. The Data Core will provide across- and within-project data management, collaboration, and statistical expertise, and partner with the Administrative and Dissemination and Outreach PHASES Cores to advance the Center and project-specific aims. For all data sources, the Data Core will acquire and store data required for and customized to each project, oversee and adhere to compliance and safety requirements, and engage Project personnel to build capacity for and execute analytic tasks. A centralized Data Core facilitates efficiency in data operations, increases efficiency across studies especially when data sources are shared, concentrates data expertise, and enhances and increases collaboration. Linkages between the Data Core and the Dissemination and Outreach Core will include an emphasis on data visualization and other innovative strategies to maximize the impact of research findings across PHASES projects. The Data Core will act as a central contact and provide Data Core staff with unified operations and data analyses to deploy the tasks required across projects. Design of the Data Core leverages unique expertise of personnel and institutional strengths of the AJ Drexel Autism Institute and Drexel University. The process for requests for data analyses conducted by Data Core faculty and staff from PHASES Projects will build capacity to advance the overall Center aims and advance public health impact by building shared and adaptable analytic approaches. The Data Core will be led by MPIs Reneé Moore, PhD, and Lindsay Shea, DrPH. The distribution of leadership responsibilities of the Data Core is based upon the expertise of the MPIs, faculty, and staff. The joint leadership provides opportunities to build synergy across data tasks of PHASES projects. The Data Core will build upon existing Autism Institute and University infrastructure to collaborate across studies; target staff development to increase efficiency across similar tasks and enhance expertise in dynamic health data management and analysis; and centralize compliance and management efforts. The Data Core combines a team with dynamic health data expertise with an established university infrastructure for safe storage and management of large-scale data to ensure smooth analytic operations and rigorous science.